Molecular Determinants of Health Disparities in Inflammatory Breast Cancer

Inflammatory breast cancer (IBC), the most lethal form of breast cancer, is a health disparity. IBC
has a greater incidence and younger presentation in African Ancestry women (AA) compared with white women
(W). IBC is also particularly aggressive in AA, who exhibit substantially shorter median survival compared to W,
irrespective of molecular subtype. The underlying causes of this disparity in clinical outcome, much of which
remains after controlling for medical coverage and treatment access, are poorly understood, severely limiting
potential strategies to close this gap. Our proposed work addresses the critical, unanswered questions - What
tumor biological mechanisms drive the more aggressive IBC biology in AA) and how can these mechanisms be
modulated therapeutically? Our epidemiological studies identify that modifiable risk factors like reproductive
factors (early age at first pregnancy, multiparity, and lack of breastfeeding) and high body mass index (BMI), are
associated with poor therapeutic outcomes and survival among AA-IBC compared to W-IBC. These stressors
have the potential to cause persistent inflammation in the mammary gland. A basic survival mechanism that is
intrinsic in both normal and cancer cells is the ability to constantly respond and adapt to stress stimuli (like
mutations, life-stressors, environmental changes, therapy) referred to as adaptive stress response (ASR).
Linking these observations, is our identification of ASR gene sets in IBC cells exposed to stress stimuli that show
race-specific differences in expression. These datasets lead to our overarching hypotheses that 1. a
heightened adaptive stress response consisting of NFκB activation, suppression of programmed cell death, and
pro-tumorigenic macrophages promotes outgrowth of invasive, metastatic and treatment resistant tumor cells in
AA-IBC; 2. pharmacologic inhibition of the ASR pathway in conjunction with macrophage inhibition will suppress
IBC growth and dissemination. To test this hypothesis, we propose Aims to (1) investigate whether AA- and W-
derived normal breast epithelial cells and IBC cell lines promote monocyte differentiation using a panel of
immortalized cell lines from core breast biopsies of AA and W healthy women and IBC cells in co-culture assays
with monocytes and how ASR pro-survival markers correlate with stromal patterns of stem cells and
macrophages in patient tissues by gene expression and immunohistochemistry analysis; (2) implant AA- and W-
patient derived IBC cell lines with differential NFκB activity in a novel macrophage-induced “early lesion” murine
model to spatially query tumor-stromal cell interactions and host macrophage infiltration during tumor initiation;
(3) investigate the ability of clinically available agents, birinapant, a “cell death booster” and zoledronic acid, a
macrophage depleting agent to inhibit growth of tumor organoids derived from AA-IBC drug resistant variants in
the ‘early lesion’ murine model. Successful completion of this project will lead to new treatment options for IBC
patients with a high unmet medical need. Importantly, new AA- and W- bio-specimens, PDX and derivative cell
lines and IBC-specific models resulting from the proposed work will be available to the scientific community.

Public health relevance
Inflammatory breast cancer (IBC), a highly lethal form of breast cancer, disproportionately affects African American (AA) compared with non-Hispanic White women (W) with hazard ratios for death 30% higher in AA compared to W even after adjusting for socioeconomic position, age at diagnosis, treatment, and hormone receptor status. Recently, we discovered that this disparity may be the result of a heightened adaptive stress response signaling in the tumor microenvironment of AA linked to IBC risk factors, which can lead to greater capacity for clonal evolution of death-resistant tumor cells contributing to aggressive, therapy-resistant disease. As the incidence is rising and targets for therapy are scant, IBC has the potential to become a major public health disparity concern. This study has the potential to lead to new treatment options, provide a biomarker for stress related progression and therapy resistance in AA-IBC, and predict those who would benefit from these targeted approaches.